ACTG 362--AZITHROMYCIN THERAPY FOR PRIMARY PREVENTION OF MYOCBACTERIUM AVIUM

Evaluate whether prophylaxis with azithromycin is still needed for the primary prevention of MAC disease in subjects whose CD4 counts increased on antiretroviral therapyp.